Supplement for Changes in Weight and Physical Function for Older African American Women in National, Peer-Led, Community-Based Weight Loss Program

Abstract of the Funded Parent Award
Older African American (AA) women have the highest prevalence of both obesity and frailty. In academic, expert-
led interventions, obese, frail, older individuals both lost weight and improved their physical function. However,
because of high personnel costs and nonexistent nationwide infrastructure, large-scale implementation of these
interventions is impractical. The long-term goals are to eliminate the health disparities of obesity and frailty in
older AA women. This proposal’s overall objective is to determine the effects of a low-cost, community-based,
peer-led weight loss program with a national infrastructure on obesity, physical function, and healthcare
utilization in older AA women. To treat obesity and frailty in older AA women, it is critical to test a weight loss
intervention that 1) has preliminary evidence of benefit; 2) is acceptable to older AA women; 3) is affordable; and
4) can be broadly disseminated. Take Off Pounds Sensibly (TOPS) is a national, nonprofit, community-based,
peer-led weight loss program that meets these criteria. First, the applicant’s retrospective database analyses of
TOPS showed two important results: 1) Participants who renew their annual membership lose and maintain
significant weight loss (SWL) for up to 7 years; and 2) Compared to their younger counterparts, older women
are more likely to achieve SWL. Second, the applicant started three TOPS chapters for older AA women in a
successful pilot study. Though the study ended in 2012, one of the chapters was active almost 8 years later until
the COVID-19 pandemic in March 2020. Third, TOPS is affordable; it only costs $92 annually. Finally, TOPS has
a nationwide infrastructure with chapters in all 50 states. Since obese, frail, older individuals in academic, expert-
led weight loss interventions can improve their physical function, the central hypothesis is that a low cost,
community-based, peer-led weight loss program with a national infrastructure can provide SWL, improved
physical function, and lower healthcare utilization for AA women, an underserved, vulnerable population. The
rationale for the proposed research is that TOPS and academic, expert-led weight loss interventions share
components critical to successful weight loss; therefore, TOPS can deliver similar outcomes. The central
hypothesis will be tested by pursuing the following aims in obese, frail, older AA women: Determine the effect of
TOPS on 1) weight change and cardiovascular disease risk factors; 2) physical function and quality of life; and
3) healthcare utilization. This project is innovative because it uses a “community to academia” approach to treat
the health disparities; our study population focuses on older AA women; our outcomes focus on weight, physical
function, and healthcare utilization; and our unique study settings. The proposed research is significant because
determining the real-world effectiveness of the TOPS program and its impact on weight, physical function, and
healthcare utilization in AA women can have a widespread impact on the older population at large. Thus, it has
the potential to reduce adverse geriatric outcomes among all older individuals.

Public health relevance
Contact PD/PI: Mitchell, Nia 3. PROJECT NARRATIVE The proposed research is relevant to public health because if a low-cost, community-based weight loss program with a national infrastructure is effective at both weight loss and improving physical function among elderly individuals with decreased physical function, it has the potential to reduce adverse geriatric outcomes. The proposed research is relevant to the part of the NIH mission that pertains to enhancing health and reducing illness and disability. Page 7 Project Narrative